The role of phosphorylation in the cellular organization of the proteome

PROJECT SUMMARY
Protein phosphorylation is the most important and most extensively studied mechanism by which cells rapidly
sense signals, transduce signals, and execute decisions. Protein phosphorylation provides a means to
dynamically regulate protein function, is integral to all cellular processes, and abnormal phosphorylation is
associated with many diseases. In our previous research, we developed and applied experimental and
computational phosphoproteomics methods to systematically interrogate the signaling network and reveal its
architecture and design principles. Our rigorous research delivered reproducible methods, which are essential
to analyze phosphoproteomes in multi-perturbation studies. Our applications delivered knowledge that is
crucially important to understand why different cell types respond differently to the same stimuli to accomplish
different functions.
Building on the methods we developed and knowledge acquired, we propose to focus our research for the next
5 years on the functional aspects of protein phosphorylation, addressing the outstanding question of how
phosphorylation regulates the organization of the cellular proteome. We will expand our studies in multiple
directions that represent the next frontier in signaling biology. First, we will identify phosphosites that are
relevant to protein functions at the proteomic scale. Second, we will study how phosphorylation regulates the
multi-level organization of the cellular proteome from transient protein interactions to subcellular organelles.
Third, we will study the differences in signaling of morphologically distinct cellular phenotypes. Fourth, we will
develop methods to include phosphorylation of tyrosine and histidine in phosphoproteomic studies. Fifth, we
will assess the impact of mutations on protein functions at the proteomic scale.
To achieve these goals, we will combine mass spectrometry-based proteomics, high throughput biochemistry,
molecular biology, advanced microscopy, cell sorting, and computational and statistical methods, placing a
strong emphasis on expanding the capabilities of current proteomic methods. This research will deliver new
methods and a wealth of knowledge of protein phosphorylation in a spatial, temporal, and functional context;
which can be expanded in many new directions. Our discoveries on the basic functioning and regulation of
proteins can have an immediate translational impact by informing us about the functional consequences of
mutations and changes in phosphorylation in disease states.

Public health relevance
PROJECT NARRATIVE This research will provide spatial and temporal knowledge on how phosphorylation regulates the function and organization of proteins in the cell, which will allow devising approaches to control cellular functions and phenotypes. This research will also provide mechanistic insight on deleterious protein variants. Collectively, this research will be relevant in combating genetic diseases and diseases where signaling malfunctions, including cancer, metabolic, neurological and infectious diseases.